Subcortical auditory feedback mechanisms in speech: Function and structure

Project Summary/Abstract When we produce speech, the auditory system reduces its response to what it expects to hear based on the motor plan. This allows the auditory system to remain vigilant of externally produced sounds while also enabling it to detect errors between the expected and actual produced sounds. Disruption of this auditory feedback mechanism during speech production has been implicated in speech disorders like persistent developmental stuttering and apraxia of speech as well as in mental health disorders like autism and schizophrenia. Previous research has suggested that much, but not all, of the auditory feedback comparison is performed in auditory cortex. Other auditory feedback processing is likely performed by earlier subcortical auditory structures, but the precise mechanisms and locations of this processing has not been explicitly investigated. In this project, I propose three aims for investigating the structure and function of subcortical auditory structures in auditory feedback processing. ?Aim 1 is to demonstrate the contribution of subcortical auditory structures to general motor­induced suppression. ?Using two complementary brain imaging techniques, we will test whether generating a sound by pressing a button results in decreased auditory subcortical activity when compared to passive listening of those sounds. ?Aim 2 is to test speech­specific subcortical auditory modulation by examining subcortical activity during speech formant feedback perturbation?. In this experiment, we will alter how participants hear themselves while they speak. Using high­resolution functional brain imaging, we will be able to see if differences between expected and actual speech feedback cause more activity in subcortical auditory structures. ?Aim 3 is to describe the structural connectivity between auditory structures and the auditory periphery using high­sensitivity diffusion­weighted imaging?. This brain imaging technique allows us to infer how neuron bundles are physically connected in the brain and extending out to the ear. Using existing data from a powerful new imaging device, we will examine neural connections between specific auditory and motor structures in greater detail than have been investigated before. We will also develop a new method to track the cochlear nerve from the brainstem to the ear in order to help clinicians determine the best hearing implant for hearing­impaired individuals. Overall, this project will provide high resolution brain imaging of subcortical auditory structures and their role in comparing expected to actual self­generated sounds. Our results will help us understand how faulty connections can contribute to speech and mental health disorders and will enable the development of more effective therapies for such disorders in the future.

Public health relevance
Project Narrative Disruption of auditory feedback mechanisms during speech production have been implicated in speech disorders like persistent developmental stuttering and apraxia of speech as well as in mental health disorders like autism and schizophrenia. This project will provide novel insights into how and where these mechanisms are performed in the brain, potentially leading to new therapies for such disorders.